Inferring the rules of antibody evolution using replicated germinal centers

PROJECT SUMMARY
Germinal centers (GCs) are the site of affinity maturation, a prototypical Darwinian process that is required to
generate the potent antibodies that protect against infectious disease. Over the past decades, work by several
groups, including our own, has led to a comprehensive general understanding of the cellular and molecular
mechanisms that drive evolution in the GC. However, this mechanistic understanding has yet to reach sufficient
granularity to allow for accurate prediction of the outcomes of GC evolution and efficient guidance of GC B cells
along predetermined mutational trajectories. Several population-level phenomena observed in GCs remain
poorly understood, including the apparent stochasticity of “clonal bursts,” proliferative sprees in which the entire
GC is taken over by the descendants of a single cell in a matter of a few days, the continuous presence of B
cells with low affinities in GCs even at late stages of the reaction, and the apparent inability of GCs to find certain
somatic mutations despite their benefit in terms of affinity. Greater understanding of these apparently aberrant
evolutionary pathways may improve our ability to predict and potentially control the output of the GC reaction. In
this application, we develop a full toolset consisting of a mouse monoclonal for Ig genes encoding an antibody
to a classic protein antigen, a deep mutational scan (DMS) experiment in which the effects on affinity of every
possible mutation in both chains of this Ig are measured experimentally, and a computational framework that
allows us to assign affinities to any Ig sequence that we recover from these monoclonal GC B cells. We will use
these tools to conduct replicated evolution experiments on hundreds of GCs, reconstructing the evolutionary
paths and affinities of thousands of B cells in the course of GC maturation. We propose to use this approach to
gain insight into how B cell evolution plays out within GCs in vivo, focusing on the interplay between
reproducibility and stochasticity in evolution. Understanding such evolutionary aspects will be important for the
field’s efforts to guide B cell clones through defined affinity maturation trajectories through vaccination.

Public health relevance
PROJECT NARRATIVE To make high-potency antibodies that both help control infections cause allergies and autoimmune diseases, B cells go through a process of Darwinian-like evolution in which those that make the most potent antibodies are preferentially selected to become antibody producers. Work in this proposal is aimed at clarifying certain key points of this evolutionary process that are not completely understood. Clarifying these points may help us induce more potent antibodies against pathogens such as influenza, HIV, and SARS-CoV2 by vaccination.